Administrative

Project Summary
The Administrative Core is responsible for the managerial oversight of the P01. This includes all administrative
and budgetary matters, scheduling advisory committee meetings as well as regular meetings of all project in-
vestigators. This Core will also work to assure that the direction and focus is periodically examined with an eye
towards clinical relevance and implementation. Reflecting the PIs interest in increasing diversity and training
the next generation of scientists in areas related to radiopharmaceutical therapy (RPT), this core will encour-
age and facilitate internships, summer student engagement, and other opportunities to expose students (at all
levels) to the work performed in the cores and projects. Specifically, this core will Aim 1: Provide overall scien-
tific leadership and managerial oversight of the P01, including integration of research activities across the pro-
jects and cores. Aim 2: Encourage scientific rigor and maintain focus on clinical relevance. Aim 3: Increase
diversity and encourage student engagement. Through these functions, the Administrative Core will provide an
essential service to each of the Research Projects and Cores to help accomplish the proposed goals and ob-
jectives of the P01. The longer-term administrative objective of this core and the overall program PI is to foster
interactions and collaborations that will endure beyond the P01 period and lead to breakthroughs in basic,
translational, and clinical research in imaging, dosimetry, and radiobiology of α-particle emitter radiopharma-
ceutical therapy.

Public health relevance
Narrative The Administrative Core will help assure that the program project is well-managed financially. This core will assure facilitate scientific review and ongoing administrative support and coordination of the program as a whole.